Modeling Lennox-Gastaut Syndrome for improved clinical and neurobehavioral outcomes

Lennox-Gastaut syndrome (LGS) is a developmental epileptic encephalopathy (seizures further contribute
to cognitive deterioration). LGS is relatively frequent (1-2 million people worldwide), accounting for 1-2% of
all patients with epilepsy, more in males. Though described in the sixties, International League Against
Epilepsy (ILAE) recently updated and focused LGS definition. LGS presents with: (1) Variable seizure types
starting before 18 years of age, however tonic seizures must be included plus one additional type. (2)
Cognitive and behavioral impairments (may not be present at seizure onset). (3) EEG must show diffuse
slow spike-and-wave as well as generalized fast paroxysmal activity. LGS commonly develops from the
severe infantile epilepsy, very often (in 20-30%) from Infantile Epilepsy Spasm Syndrome (IESS).
Conversely, 20-50% of infants with IESS transition to LGS, especially those with structural- metabolic
etiology of IESS. Lamotrigine, felbamate and possibly topiramate may be helpful in treatment of drop
attacks (atonic seizures) associated with LGS. Recently, fenfluramine appears to be promising in the
reduction of drop attacks and tonic-clonic seizures in patients with LGS. LGS is otherwise very refractory,
persists till adulthood, and remains resistant to therapy resulting in intellectual disability in more than 90% of
patients. There is no animal model of LGS that would assist in testing new more effective treatments to
improve dire neurobehavioral prognosis in most patients with LGS. The goal of this proposal is to develop
model of LGS for testing novel treatments. In the R61 phase, the model will be developed and quantified.
R61 Specific Aim is to fully characterize spontaneous electroclinical signs of the LGS model in large cohorts
of prepubertal rats based on two complementary etiologies found in human condition (two different models
of IESS = two experimental arms). The milestone determining GO/NO GO transition to the R33 phase
is the 40% occurrence of electroclinical features of LGS (both EEG and behavioral signs in a single
subject) in model animals. R61 Specific aims are to provide external validation to the developed LGS
model. If successful, the R33 phase will complete external validation in terms of face validity (adding
behavioral testing on top of electroclinical features), comparing etiological efficacy for construct validity, and
testing two different treatment paradigms used for LGS in humans as predictive validity. Methods use
preparation of the IESS models and controls, intracranial surgery, EEG electrode implantation, 24/7 video-
EEG recordings and analysis, drug administration, as well as separate cohort behavioral testing for motor
behaviors, anxiety, autistic traits and cognition. Purpose of the LGS model development is to provide a tool
for testing new treatment approaches for this devastating developmental epileptic encephalopathy.

Public health relevance
The goal of this proposal is to develop a model of Lennox-Gastaut syndrome, a devastating developmental epileptic encephalopathy, in rats in relevant stage of postnatal development. The model will use etiologically relevant platform and will be internally and externally validated. Purpose of the model is testing new prospective treatments of Lennox-Gastaut syndrome.